IGF::OT::IGF DATA SET #2013-1 - PROVIDE DATA SET FOR CENSUS TRACT DATA 2010 TO 2020 (BASED ON 2010 GEOGRAPHIES).

Obtaining annual population estimates for counties and census tracts based on the counts produced by the US Census Bureau